GENETIC ANALYSIS OF HIRSCHSPRUNG DISEASE

To identify the genes predisposing to Hirschsprung Disease and to clarify the genetic heterogeneity by means of (1) segregation analysis of retrospective family history medical data; (2) cytogenetic analyses; (3) linkage studies using molecular markers.